The Effects of Unintended Pregnancy on Children

ABSTRACT
In the United States, nearly half of pregnancies are unintended, and unintended pregnancies occur five times
more often among poor women compared to affluent women. The proposed project investigates how providing
access to free contraceptives impacts unintended pregnancy and, ultimately, the lives of children—both children
whose births are unintended and their older siblings who may lose resources (both material resources and time)
as a result of a mother’s unintended pregnancy.
The proposed project significantly expands the scope of Michigan Contraceptive Access, Research, and
Evaluation Study (M-CARES), a large-scale, randomized control trial that provides no-cost access to any type
of contraception and tracks women longitudinally in surveys and rich, administrative data. The proposed project
aims to:
(1). Double the M-CARES recruitment period and increase the sample of children born before the
intervention that are in the study by 1,000;
(2). Develop and field two survey supplements (year 2 and year 4 post enrollment) of M-CARES
participants to ask about (a) intendedness of each birth (pre- and post-intervention), (b) time and
money spent on each child, (c) parenting practices, and (d) children’s health, schooling, extra-
curricular activities, behavior and well-being;
(3). Compile comprehensive longitudinal data using surveys (aim 2) and administrative records to
document the outcomes of the children of M-CARES participants in (a) the short-term (5-year study
period) and (b) long-term (until children reach age 18); and
(4). Evaluate the causal effects of mothers’ access to free contraception on children’s outcomes in survey data
(aims 2a-d) and administrative records (3a), including heterogeneity analyses by income, race, and
education.
Achieving these aims will contribute to social science and public health policy by providing novel experimental
evidence on the understudied, intergenerational effects of making contraception free to women within the existing
U.S. public health system. This study will, therefore, contribute to a larger cost-benefit analysis of a feasible and
easy to implement reproductive health intervention—an intervention that potentially helps break the cycle of
poverty and improve children’s life-time opportunities.

Public health relevance
PROJECT NARRATIVE This project contributes to public health knowledge by building on the Michigan Contraceptive Access Research and Evaluation Study (M-CARES) to evaluate the long-term effects of mothers’ access to free contraceptives and reductions in unintended pregnancies on an understudied group: children. By providing a more comprehensive evaluation of the intergenerational benefits of subsidies for contraception in the U.S., this study informs the implications for changes in Title X funding under the Public Health Services Act.